Archive Data Core

The overall Program Project proposes to make the archive data stored at the Florida Center for Reading Research (FCRR-DW) available to the Principal Investigators for the projects. The specific objectives of Core D are to (a) query student, classroom, school, and district level data for Principal Investigators, and (b) ensure the accuracy and confidentiality of the archive data. All investigators from the projects will be able to meet with the Project Director to discuss the research questions and determine the extent to which the data available in the FCRR-DW will meet their needs.